2025 Developmental Biology Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
Funds are requested to provide partial support for the 2025 Gordon Research Conference and Gordon
Research Seminar in Developmental Biology to be held from March 29- April 4, 2025, in California, US. This
meeting has been held at 2-year intervals for the past four decades and has brought together outstanding early
career and established scientists to share recent advances in the field of development and disease
mechanisms building an outstanding and most prestigious mid-size scientific meeting. The meeting in 2025 is
focused on the emergence of patterns and shapes in development integrating intrinsic cues from self-
organization to the influence of extrinsic environmental impact on development. In 2025, 23 invited speakers,
chosen based on their creative contributions to the field the field and their ability to promote fruitful discussions,
have confirmed their attendance, of which eleven are men, and twelve women: three Black scientists, one
Hispanic scientist, and two Asian scientists, representing nine countries. Chairs will select speakers from
poster abstracts to further diversify the program. All participants will be given the opportunity to present their
work in poster sessions. By providing a unique opportunity for interactions with senior leaders in the field the
Gordon Research Conference and Gordon Research Seminar in Developmental Biology, 2025 expects to
define both the present state and the future of the field with a focus emergence of patterns and shapes in
development. The meeting has several unique features. It is attended by the entire international field working
on diverse organisms and cell systems advancing biology at various cellular and developmental levels, and at
this time, this community will focus on specific topics and their current state of knowledge. The objective of this
meeting is to exchange information, using a comparative approach to advance our understanding in various
processes linking developmental biology. Many collaborations have resulted from these meetings: reagents
were exchanged, experiments planned and new ways of looking at development and disease mechanisms
have evolved. Topics for this year will revolve around the stem cell models, cell fate decisions, gene regulation,
mechanics in development, morphogens and metabolic control, evolutionary principles and developmental
disorders emanating from loss of principles of development.

Public health relevance
PROJECT NARRATIVE Funds are requested for partial support of the 2025 Gordon Research Conference and Gordon Research Seminar on Developmental Biology. The pre-eminent mid-sized meeting in the field, this conference promotes interaction among diverse investigators from all career stages who use a multitude of organisms and technologies to define the molecular, cellular and genetic processes that control how bodies are shaped and maintained, with specific emergence of patterns and shapes in development, from self-organization of embryos (both ex vivo and in vivo) to impact of metabolic and environmental control as well as developmental disorders that emanate from these processes going awry.